Estrogen-mediated effects on neutrophil function and airway inflammatory response

Project Summary
Cystic Fibrosis (CF) and nonCF bronchiectasis (NCFB) are characterized by thickened respiratory secretions,
chronic lung infection and neutrophilic inflammation. A host of epidemiologic data demonstrates that females
with CF suffer from increased pulmonary exacerbations, earlier colonization with bacteria such as Pseudomonas
aeruginosa (PsA) and decreased life expectancy relative to males with CF. Similarly, NCFB is more common in
females and associated with worse outcomes in females relative to males, but the etiology behind these sex
disparities is unclear. A leading candidate to explain this disparity is an estrogen-dependent effect on
inflammation and immunity given that our work and the work of others demonstrates higher sputum inflammatory
markers and increased pulmonary exacerbations at times of high estrogen levels (ovulation) in females with CF.
Moreover, we found that suppressing endogenous 17β-estradiol with hormonal contraception improved these
markers of health. Our central hypothesis is that estrogen causes dysregulated neutrophil function and
inflammation leading to a sex difference in lung disease and outcomes in people with CF and NCFB.
CF respiratory disease is characterized by a sustained influx of neutrophils into the lungs in response to bacterial
infection and inflammation. A major mechanism for neutrophil killing is the release of web-like neutrophil
extracellular traps (NETs) that trap and kill a variety of microbes. Although NET formation is an important event
in innate immunity, excess NETs can be detrimental by producing pro-inflammatory stimuli and proteases that
amplify lung damage. Our preliminary studies show that: (1) neutrophils from females with CF and NCFB kill less
PsA than neutrophils from males; (2) estrogen decreases neutrophil killing and upregulates NETosis and
inflammatory mediator release.
We aim to answer several key questions including: (1) what estrogen receptor is driving the estrogen effect on
neutrophils (2) what other downstream pathways are involved (3) what is the context of these findings in cis and
transgender individuals (4) Are the findings unique to CF or applicable to other chronic inflammatory airway
diseases such as non-CF bronchiectasis (NCFB). The expected outcome of this research is a comprehensive
understanding of how estrogen mediates functional activity of the neutrophil and the pathways involved that can
reveal therapeutic targets, including the potential use of nebulized estrogen receptor antagonists to combat the
disproportionate chronic inflammatory process present in cis and trans women with CF.
The long-term goal of our lab is to understand the mechanisms leading to sex and gender differences in CF and
to develop novel therapies to narrow the disparity. The objective of this proposal is to understand the estrogen-
specific effect on neutrophil dysregulation and inflammation. The impact of this proposal is significant because it
may lead to treatments that can improve the health of people with CF and NCFB and guide therapies for other
chronic inflammatory airway diseases with similar sex and gender disparities.

Public health relevance
Project Narrative Cystic fibrosis (CF) is characterized by thickened respiratory secretions, recurrent airway infection and neutrophilic inflammation resulting in progressive lung function decline; females with CF experience more pulmonary exacerbations and earlier mortality than males and show increased sputum inflammatory markers in association with high estrogen levels. This proposal will evaluate the effect of estrogen on neutrophil NET (neutrophil extracellular trap) release and inflammatory cytokine production and determine pathways involved using human cells, mouse models and samples from cis and transgender people with CF. The proposed research is relevant to public health because understanding how estrogen impacts neutrophilic inflammation in CF and non-CF bronchiectasis may help guide therapeutic targets, including nebulized estrogen receptor antagonists, and aims to decrease the sex disparity in CF and other chronic inflammatory respiratory diseases.